Mentoring in Data Science for Big Data and omics in Immunologic Diseases

ABSTRACT
Accurate and automated prediction of disease outcomes has the potential to significantly improve patient
health by informing personalized interventions for individual patients. Distinguishing which patients will
progress to more severe disease from patients who will require minimal intervention at the time of diagnosis
remains an urgent unmet need. In this proposal, Sana Syed, MD, MSCR, MSDS will solve this gap by training
junior clinical investigators in novel approaches for integrating data science into multi-omic big data. The
training provided in this award will expand the number of patient-oriented clinical investigators able to apply
data science approaches to complex research problems and improve precision medicine research into
immunologic diseases of the gastrointestinal tract. By leveraging large cohorts of patient-derived heterogenous
big data, trainees can identify novel biomarkers and therapeutics, better predict future outcomes of disease,
and provide better, more individualized medical care.
Dr. Syed has established a track record of impactful training to researchers and clinicians at all stages of their
careers, from high school to junior faculty. Her mentoring success has been underpinned by leveraging her
existing research projects to provide training opportunities in the realm of data-science driven immunologic
disease and precision medicine research. In this award, she will further expand her training approach to use
several research infrastructures for training, including R01, foundation, and three large clinical trial projects
through the Duke Clinical Research Institute. The biospecimens, data science tools, and heterogenous patient-
derived health data within these studies will provide an immense volume of data to support a multitude of
trainee projects.
The largest clinical trial projects Dr. Syed is associated with at the DCRI houses a number of clinical trials,
each focused on various aspects of child and maternal health. These projects are led by experts and physician
scientists focused on patient-oriented research with expertise in operationalizing global studies. This training
program will leverage the immense volume heterogenous big data collated through these existing and
prospective projects (over 4500 GI biopsies from over 750 subjects) to support opportunities for trainees in a
variety of fields pertaining to infectious and immunologic disease. Moreover, the collaborative networks within
all of these projects will allow trainees to access intellectual and technical support from leading experts in
numerous fields and approaches, further amplifying the quality of training they will receive.

Public health relevance
NARRATIVE Data tools can significantly improve medical care by providing better treatments that are tailored to each patient. This application proposes training junior clinicians to apply computer-aided analyses to large volumes of different types of data collected during standard medical care to find new ways to diagnose and treat disease. The applicant has an excellent track record of mentorship and seeks to expand their training to clinical investigators who will conduct high-quality research into infectious and autoimmune diseases in adults and children.